Cell Imaging Core

PROJECT SUMMARY: CELL IMAGING MODULE
The Vanderbilt Vision Research Center (VVRC) includes faculty investigators with a strong interest in
discerning structure-function relationships in the visual pathways. These include inferences based on whole
tissue analysis, single cell labeling, and localization of molecular components of biochemical cascades in
involved in intra- and extracellular signaling. Such inferences require access to not only expert histological
processing and labeling, but also sophisticated high-resolution microscopy imaging platforms. The purpose of
the VVRC Cell Imaging Module is to provide a comprehensive resource for light and electron microscopy
imaging by supplying support for managerial personnel of the Vanderbilt Cell Imaging Shared Resource
(CISR), which includes a new Nikon Center of Excellence housed in the Department of Cell and
Developmental Biology (Medical Center North). This support translates on a dollar-for-dollar basis to
scholarships issued to VVRC investigators applicable for all CISR services, including the Nikon Center for
Excellence. This scholarship system is implemented by the VUMC Office of Research and is utilized instead of
a discount or co-pay via the VUMC ILab accounting system. In the current funding cycle, the Cell Imaging
service was used by 19 investigators, 15 of whom authored 73 publications using the service, and saved our
investigators $207,455 through issuance and utilization of 69 scholarships. In the next cycle, we expect
moderate to extensive use by 21 of 36 investigators. The Cell Imaging Module, housed in centralized locations
sufficient for 19 independent microscopy platforms, is directed by Associate Professor Rebecca M.
Sappington, PhD. Using resources and personnel supported in part by this Core mechanism, the VVRC Cell
Imaging Module will provide (1) a broad range of imaging modalities suitable for visual system tissues, (2)
state-of-the-art image analysis software and data storage solutions, (3) consistent monitored access to imaging
equipment and workstations, (4) imaging consultation on appropriate imaging modalities and sample pre-
processing for visual system cell and tissue samples, and (5) training in the full spectrum of imaging modalities
available in the CISR. These services and resources will enhance the scope of experimentation NEI-funded
VVRC investigators conduct, expand the training of students and fellows involved in vision science, and
promote collaboration by providing sophisticated, high-resolution and diverse imaging technology to those who
otherwise would not have such capabilities, including early-career vision scientists and clinician-scientists
competing for extramural funding for their laboratories.